UCSF Older Americans Independence Center

PROJECT SUMMARY ABSTRACT – Overall UCSF Older Americans Independence Center (OAIC)
The UCSF OAIC theme is "Predictors, Outcomes, and Amelioration of Late-life Disability: A Focus on
Vulnerable Populations." Late-life disability will affect 80% of older Americans, has a profound impact on
patient and caregiver quality of life, and carries large costs. These challenges have special resonance for older
adults who are vulnerable, which we conceptualize as a complex interplay of both medical vulnerability (such
as cancer in persons with complex multimorbidity) and social vulnerability (such as social isolation or poverty).
We are deeply committed to advancing the science of preventing and ameliorating disability in older adults with
these vulnerabilities, in large part by mentoring and supporting the future leaders of aging science who will
develop this theme. During our first 9 years, the UCSF OAIC has supported and mentored an interdisciplinary
community of investigators whose paradigm-shifting research that has changed clinical practice and policy and
yielded major advances in our understanding of disability, including elucidating inextricable linkages between
medical and social vulnerabilities. We have been a galvanizing force at UCSF, infusing aging science into a
wide array of specialties and disciplines. Our dedication to developing the next generation of researchers has
led to publications in the highest impact journals, R01 awards, an unprecedented number of GEMSSTAR and
Beeson Awards, and mentorship awards for OAIC Leaders.
During the next cycle, we will build on our track record of success while growing and innovating in new
directions to respond to emerging opportunities. Our two resource cores – the Data and Analysis Core (DAC)
and the Vulnerable Aging Research Core (VARC) - will catalyze a wide spectrum of clinical and outcomes
research. Our Research and Education Component (REC) Scholars and Pilot and Exploratory Studies (PESC)
Scholars will be provided the resources, mentorship, and community to build a platform for long-term research
success in our theme area. Our Leadership and Administration Core (LAC) will guide the Center's activities
and mission and ensure tight integration between all of our Cores and activities. Together, we will advance our
center's 5 aims: to (1) Catalyze research on disability in vulnerable older persons by serving as a hub that
brings together scholars and leverages resources to advance aging disability science and career development;
(2) Provide core access to data resources, statistical support, and expertise enrolling and retaining vulnerable
older subjects in order to stimulate new research on disability; (3) Identify the future leaders of geriatrics
research and catalyze their development with career development funding and exceptional mentoring; (4)
Support pilot studies that accelerate aging science and lead to research funding in late life disability; and (5)
Develop a leadership and administrative structure that spurs interdisciplinary collaboration, making the OAIC
greater than the sum of its parts.

Public health relevance
PROJECT NARRATIVE – Overall UCSF Older Americans Independence Center (OAIC) The UCSF OAIC provides investigators a comprehensive suite of resources, mentorship, and support to advance science in our theme area, which is focused on predictors, outcomes, and amelioration of late-life disability in medically and socially vulnerable older adults. We seek to continue our superb track record of developing an interdisciplinary cadre of investigators whose research yields major, clinically impactful advances in our theme area and is ultimately translated to improving care and quality of life for vulnerable older adults with or at risk for disability.